Contributions of Volume Overload Level and Ultrafiltration to Morbidity in ESKD

Project Summary/Abstract
The long-term goal of this proposal is to modernize clinical methods for assessing fluid excess for removal
during in-center hemodialysis treatment using newer assessment techniques. The experience of trial-and-error
assessment of a “dry weight,” a weight at which a patient can tolerate fluid removal without the development of
symptoms of hypovolemia or hypervolemia, a common practice for over 50 years, that may have a lasting
effect on the ability to function for nearly 500,000 Americans who depend on hemodialysis for survival. Newer
techniques for quantifying excess extracellular volume for removal during hemodialysis do exist. Small studies
have suggested the potential utility of multi-frequency bioelectrical impedance spectroscopy (BIS) as a means
to improve on clinical dry weight estimates to guide intradialytic ultrafiltration. Moreover, the rate at which fluid
is removed during hemodialysis has been limited to not exceed 13ml//kg/hr based on observational studies on
mortality. However, this association may differ relative to an individual's body size and may be more of a
reflection of persistent volume overload rather than the just the rate of removal itself. The crude imprecise
practice of dry weight assessment together with limitations in ultrafiltration rate may contribute to adverse
patient experiences including persistent volume overload with peripheral edema and dyspnea on one hand,
and intradialytic hypotension, fatigue, and muscle cramping on the other. Dialysis treatment day BIS estimation
of excess extracellular fluid to direct ultrafiltration has the potential to improve patient-centered outcomes, the
overarching premise of this proposal. We will gather evidence on the potential utility of BIS to improve the
patient experience immediately following and during the post dialysis period. Our findings will inform future
studies testing whether use of BIS to guide fluid removal during dialysis can improve how patients feel,
function, and survive. We propose to compare dry weight estimation by BIS to usual care including estimate
discordance on patient centered outcomes (Aim 1). We will also quantify the relative impact of high
ultrafiltration rate and achievement (or non-achievement) of BIS-estimated target weight on patient physical
function, sleep and quality of life (Aim 2) and examine clinical decision-making and patient perspectives on
how UF management influences patients' dialysis experience using qualitative methods (Aim 3) among adults
receiving hemodialysis in two metropolitan areas. The National Kidney Foundation's Kidney Disease
Outcomes Quality Initiative (KDOQI) and the Kidney Disease Improving Global Outcomes (KDIGO)
organizations are actively examining patient centered ways to improve care quality, the proposed work aligns
with these efforts.

Public health relevance
Project Narrative The long-term goal of this proposal is to improve on clinical methods for assessing “dry weight,” the lowest weight at which a patient can tolerate fluid removal during in-center hemodialysis without symptom development. By current methods, patients commonly experience adverse events, including persistent volume overload with peripheral edema and dyspnea on one hand and intradialytic hypotension, fatigue, and muscle cramping on the other. We will gather evidence on the utility of multi-frequency bioelectrical impedance spectroscopy as a means to improve on clinical dry weight estimates to guide intradialytic ultrafiltration which will serve as the foundation for a larger trial to improve the patient experience during, immediately following and on days after hemodialysis treatment.